Partnering for Precision Medicine: A Collaborative Services Center for the All of Us Program

ROA Number OTA-23-002 | Partnering for Precision Medicine:
A Collaborative Services Center for the All of Us Program3
ABSTRACT
The All of Us Research Program (AoU) aims to broaden its reach and impact by enabling
support for a continuously evolving set of engagement, enrollment, and retention partnerships,
participant audiences (including children), assessment methods, research services, ancillary study
protocols, and return of information to participants. Through the establishment of the AoU
Participant and Partner Services Center (PPSC), the program will build on its prior successes to
provide technology systems and direct and indirect research services to enable and support
participant engagement, enrollment, and retention in collaboration with program partners.
The key to the success of the PPSC is understanding the research process and building
technological and methodological solutions that allow the AoU program to meet the needs of
AoU participants and partners. As the PPSC partner, NORC will collaborate with NIH and other
AoU partners to enroll a diverse population while maintaining engagement from the participants
already enrolled. Additionally, the PPSC will support the expansion of AoU to include new data
collection methods and ancillary studies.
Our proposal for the PPSC Research Technology Systems (RTS) Core combines our deep
knowledge of multimodal data collection with technical expertise to design and configure the All
of Us Participant Management System (APMS), based on a Salesforce and Qualtrics platform.
These widely-used, secure, low-code/no-code platforms will allow for rapid implementation of
the APMS and also facilitate future enhancements and additions to the AoU protocol.
For the Program Management and Delivery (PMD) Core, we will provide indirect and direct
research services supporting program and protocol operations for the AoU as it moves into the
next phase and expands the scope to enroll children, conduct ancillary studies, and improve
outreach to diverse communities.
Full Participant and Partner Services Center
Technical Proposal Use or disclosure of data contained on this page is subject to the restriction on the cover sheet of this proposal or quotation.